Symptom Dimensions in Psychosis

[unreadable] DESCRIPTION (provided by applicant): This is an application for a 5-year Mentored Clinical Scientist Development Award (K08). The candidate has received training in human genetics and additional training in psychiatry. The goal for this award is to develop the candidate's skills in gene mapping of complex traits, such as psychiatric disorders, using symptom dimensions and neurophysiologically defined endophenotypes as traits. During the time of the award, the candidate will acquire knowledge in the application of newly developed statistical methods to address the problem of clinical heterogeneity in patient samples with psychotic disorders. Understanding the heterogeneity in these disorders is one of the major challenges in the attempt to identify underlying genetic mutations. Defining the differences in clinical symptoms and neurophysiologic functioning is therefore of utmost importance. Several recent findings suggest that this approach to gene identification is useful. The long-term aim of the candidate is to understand the cognitive, emotional, behavioral and neurophysiologic abnormalities of psychotic disorders, their overlaps and their differences and to link these to molecular abnormalities. This may, if successful, enhance the understanding of these disorders and improve diagnostics and treatment. The training goal will be reached using the following steps: 1. A combination of factor analysis and latent class analysis (factor mixture model) will be used to subgroup patients from the NIMH schizophrenia and bipolar genetics initiatives. 2. Linkage analysis and quantitative trait locus mapping will be performed on these so defined subgroups. 3. Experience in the use of endophenotypes for genetic studies will be obtained through participation in ongoing studies at UCLA. The Neuropsychiatric Institute at UCLA provides the ideal environment for this proposal. The mentorship of Dr. Nelson Freimer, Dr. Andrew Leuchter and Dr. Bengt Muthen, who are all experts in overlapping aspects of this proposal, will guarantee the success of the training, complemented by coursework and conferences. [unreadable] [unreadable] [unreadable]